Osteoclast-Independent Mechanisms of Early-Stage Bone Colonization of Breast Cancer

Project Summary
Overt metastases are often diagnosed years after the removal of primary breast tumors, indicating the existence
of systemically disseminated tumor cells or microscopic metastases. Adjuvant therapies have been designed to
eliminate these cells. Although significant advances were made, a substantial proportion of patients still develop
overt metastases, accounting for over 90% of breast cancer-related deaths. How micrometastases resume
aggressive outgrowth and become incurable overt metastases remains poorly understood. Our long-term goals
are to elucidate the biology underlying the survival and progression of microscopic metastases and to design
therapeutic strategies against these latent tumor cells. The overall objective of this project is to investigate how
tissue homeostasis of the bone, the organ most frequently affected by metastatic breast cancer, dictates the fate
of bone micrometastases (BMM). Bone and bone marrow comprise of several highly distinctive
microenvironment niches. Dormant disseminated tumor cells (DTCs) may reside in the perivascular niche,
whereas proliferative BMM were found in the osteogenic niche that exhibit features of active osteogenesis (the
bone-making process). It remains elusive how cancer cells are relocated from one niche to another, and switch
their fates from dormancy to outgrowth. In search for such mechanism, we observed an interesting “migration-
by-tethering” phenomenon: cancer cells can adhere to osteogenic cells such as mesenchymal stem cells (MSCs)
through a dendritic spine-like structure (DSLS) that is highly pliable and elastic. Like dormant DTCs, resting
MSCs also localize in perivascular niches. Turnover of bone tissues releases signals to mobilize and chemo-
attracted MSCs to sites needing osteogenesis, thereby providing a possible vehicle for cancer cells to “ride” and
relocate from the perivascular niche to the osteogenic niche. The subsequent differentiation of MSCs will then
fuel the development of the osteogenic niche, and directly promoting metastasis progression. These findings
lead us to hypothesize that the bone turnover process may recruit both osteogenic cells and DTCs via a
“migration-by-tethering” mechanism, and foster the development of osteogenic niche to pro-mote bone
colonization. We will test these hypotheses by pursuing the following specific aims. Aim 1. To molecularly dissect
the “migration-by-tethering” mechanism and determine its role in the development of the osteogenic niche and
early-stage bone colonization of DTCs. Aim 2. To determine the impact of perturbations of bone turnover on
bone metastasis, and assess how this impact is mediated by the “migration-by-tethering” mechanism that recruits
DTCs to the osteogenic niche. The proposed research will have impact at multiple levels. At a cellular level, it
will elucidate how cell migration can occur with assistance of microenvironment cells but without acquisition of
cancer-intrinsic migratory traits. At a physiological and pathological level, it will establish connections between
bone homeostasis and bone metastasis, reveal etiology of late-onset bone recurrences, and provide therapeutic
insights.

Public health relevance
Narrative How disseminated tumor cells (DTCs) initiate the metastatic colonization process in the bone remains poorly understood. We discovered that DTCs may establish direct cell-cell contact with mesenchymal stem cells (MSCs) in the perivascular niche, and co-migrate toward the site of osteogenesis upon activation of bone turnover. We propose to investigate the molecular mechanisms underlying DTC-MSC interaction and assess the impact of bone turnover on early-stage bone colonization of breast cancer cells.